Development of TP-317 in Ulcerative Colitis

ABSTRACT
Ulcerative colitis (UC) is a chronic, relapsing disease characterized by inflammation and ulceration of the colon
and rectum that affects approximately 1.5 million people in the United States.1 Unfortunately, existing therapies
have significant limitations. 5-ASA or mesalamine, which is approved as first-line therapy for UC, is effective in
only 50% of UC patients and corticosteroids are not recommended for long-term use due to potentially serious
side effects.6 While several classes of biologics and immunomodulators have been approved for UC in the last
decade (e.g., anti-TNF-α, IL-12/23, α4β7, JAK and S1P), these drugs are approved only for moderate-to-severe
UC, are incompletely effective, and have an increased risk of serious infection and malignancy.2 Moreover,
biologics require parenteral administration, which is inconvenient and costly, and do not have durable effects for
many patients.7 Thus, there is a critical unmet need for a safe, oral treatment as an alternative to
immunosuppressive drugs for mild-to-moderate UC patients who are not well controlled by 5-ASA.
Thetis Pharmaceuticals is developing TP-317, a first-in-class Resolvin E1 (RvE1) oral therapy for UC. TP-317 is
a patented new molecular entity with enhanced stability compared to RvE1 as the natural material that can be
formulated as an oral dosage form. Under a prior NIH SBIR Fast Track grant (RDK116460) completed in 2021,
Thetis successfully conducted multiple investigational new drug (IND)-enabling studies with TP-317, including
efficacy and pharmacokinetic studies, non-clinical toxicology and development and scale-up of a proprietary
process for synthesis of TP-317. In a pre-IND meeting, the FDA indicated that Thetis can undertake clinical
development under a Phase 1 study in healthy volunteers with no additional toxicology studies. The Phase 1 will
be initiated in 2023. The goal of this Phase IIB SBIR program is to complete key non-clinical toxicology studies
to enable rapid advancement of TP-317 into Phase 2 clinical trials in UC patients.
Aim 1: Investigate TP-317 in Sub-chronic Toxicology Study in Rat (Year 1). We will conduct a 13-week GLP
toxicology and toxicokinetic (TK) study in Sprague Dawley Rat with TP-317 administered via oral gavage.
Aim 2: Investigate TP-317 in Sub-chronic Toxicology Study in Dog (Year 2). We will conduct a 13-week
GLP toxicology and TK study in Beagle dog with TP-317 administered via oral gavage.
Aim 3: Evaluation of TP-317 in Reproductive Toxicology Studies (Year 3). In Aim 3a, a fertility and early
embryofetal development safety study will be conducted in Sprague-Dawley rats to assess the effects of TP-317
on gamete maturation, epididymal sperm maturation, reproductive function, mating behavior, rates of fertilization
and implantation, and pre-implantation development. In Aim 3b, embryofetal development studies will evaluate
the effects of TP-317 on embryonic organ formation, growth, and development in pregnant rat and rabbit.
Successful completion of the Phase IIB program will enable Thetis to initiate a Phase 2 clinical trial in UC.

Public health relevance
NARRATIVE Ulcerative colitis (UC) is a growing global health problem affecting approximately 1.5 million people in the US alone, and is a growing and significant unmet medical concern. Oral agents that are safe and effective for the induction and maintenance of UC remission are in dire need as additional treatment options, and to limit the use of drugs with potentially severe side effects. Thetis plans to investigate TP-317, an innovative and potential first in-class therapeutic agent, as an oral therapy for the induction and maintenance of remission of intestinal inflammation and symptoms in UC patients. .